Administrative Core-001

ADMINISTRATIVE CORE ABSTRACT
The University of Alabama at Birmingham {UAB}'s Center for Cancer Control in Persistent Poverty Areas (C3P2) will expand research and research capacity in cancer control in persistent poverty (PP) areas of Alabama by implementing and evaluating multilevel interventions to improve cancer outcomes across the cancer control continuum from prevention to survivorship. The coordination and management of the C3P2 will be accomplished through this Administrative Core (AC) which builds on the infrastructure, experience, and success of several previous large-scale centers and projects led by the current leadership team, such as the Gulf States Collaborative Center for Health Policy Research {NIMHD U54, MPI: Pisu), the Obesity Health Disparities Research Center {NIMHD U54, Pl: Fouad}, and the Mid-South Transdisciplinary Collaborative Center for Health Disparities Research (NIMHD U54, Pl: Fouad), the Emotional Well-Being and Economic Burden Research Network (EMOT-ECON) (NCCIH U24, MPI: Pisu), and the Recruitment and Retention and Assessment and Analysis Shared Resources of Adapting MultiPLe behavior Interventions that eFfectively Improve (AMPLIFI) Cancer Survivor Health (NCI P01, Core Lead: Pisu). The AC will be responsible for the overall management of the center, to include fiscal management, coordination among cores, research projects, and pilot projects; implementation of communications and outreach plans to promote team science, community engagement, and dissemination; and the conduct of a robust evaluation to ensure the progress of the center and alignment with other centers.